RECOMB INTERFERON BETA THERAPY IN PTS W/ CHRONIC HEPATITIS B &C--DOSE RANGING

This is a dose ranging study to identify a tolerated dose of recombinant interferon beta that will demonstrate efficacy in patients with chronic hepatitis B and C.